Administrative Core

The goal of the Administrative Core is to provide an efficient administrative structure and coordination of resources to facilitate cohesive functioning of the Caribbean Exploratory Research Center of Excellence Phase II. This goal will be addressed through the following specific aim: 1. Continue to provide a centralized administrative structure, coordination and resources to facilitate cohesive function of the Center of Excellence for the conduct of research, training and education on health inequities and disparities.